DEVELOPMENT OF MASS SPECTROMETRIC METHODS FOR BIOCHEMICAL ANALYSIS

The ion trap mass spectrometer has been modified to produce high resolution and high mass spectra. The TSQ 700 triple quadrupole mass spectrum has been modified to overcome pumping problems. A series of experiments has determined the ideal operating parameters and the effects of salts and buffers.